Control of muscle gene expression by signaling pathways

[unreadable] DESCRIPTION (provided by applicant): The overall aim of this proposal is to fill the gap of knowledge on how intra-cellular signaling pathways convert environmental cues into chromatin modifications to regulate gene expression during muscle differentiation. The elucidation of the molecular basis by which the information transmitted by signaling cascades is deciphered by chromatin-binding proteins and broadcasted to other components of the transcription machinery will reveal new targets for selective pharmacological interventions aimed at modulating gene expression to influence muscle growth and regeneration in normal and pathological conditions. In specific aim 1, we will investigate how the chromatin remodeling SWI-SNF complex discriminates between the information transmitted by the differentiation-activated p38 signaling vs stress- or inflammation- activated p38 and JNK cascades. We will test the hypothesis that distinct phosphorylation patterns of the structural sub-units of the SWI/SNF complex - the BAF proteins - by differentiation- vs stress/inflammation- activated pathways establish the code that regulates SWI/SNF recruitment to the chromatin of muscle genes. In specific aim 2, we will elucidate the molecular basis of acetyltransferase recruitment to the chromatin of muscle-gene regulatory elements in response to the pro-myogenic signaling elicited by IGF-1. We will test the hypothesis that AKT-mediated phosphorylation of specific residues located within the C/H3 region of the acetyltransferase p300, promotes the interaction with the muscle regulatory factor MyoD. In specific aim 3, we will investigate whether the recruitment of SWI/SNF to the promoters of proliferation genes, which are silenced during differentiation, is also directed by the p38 pathway. We will also study the mechanism by which the cytostatic activity of differentiation-activated p38 converts the IGF1-activated pathway from a mitogenic to a pro-myogenic signaling. We will take advantage from information and reagents generated in specific aims 1 and 2 to study the functional interdependence between the p38 pathway and the PiSK/AKT signaling at the chromatin level. This study will improve our knowledge on the molecular mechanism by which sjgnal transduction pathways regulate gene expression during muscle formation, growth and regeneration. The results gathered from this proposal will have an impact on regenerative medicine, as they will eventually reveal new targets for pharmacological strategies to selectively modulate gene expression in the therapy of neuromuscular disorders and other pathological conditions accompanied by muscle loss, such as cancer-associated cachexia and aging-associated sarcopenia. [unreadable] [unreadable] [unreadable] [unreadable]